The effect of body composition on patient-centered outcomes in advanced interstitial lung disease

Project Summary/Abstract
Interstitial lung diseases (ILD) are a group of chronic lung diseases characterized by progressive fibrosis
and loss of lung function over time. Prior research has appropriately focused on respiratory function and
attenuation of disease progression; however, the myriad impacts of ILD on health beyond the respiratory system
are less well studied. Reflecting these insights, the American Thoracic Society has emphasized the need to
incorporate patient-centered outcomes (PCOs) in ILD research. Patients with ILD suffer from lower quality of life,
increased functional limitation, and increased frailty, but the extrapulmonary drivers of the impacts are not well
defined.
My early findings have identified body composition as a novel risk factor for poor outcomes in advanced
ILD. Obesity – a pathologic state of elevated fat mass – and sarcopenia – a pathologic state of low muscle mass
and function, have been associated with worse functional status, reduced quality of life, and increased disability.
As age increases, for a given body mass index (BMI), people experience an increase in adiposity and decrease
in muscle mass and function. At their extremes, this parallel change is termed sarcopenic obesity, which appears
to have multiplicative impacts on health. These aging-related changes in body composition, and the limitation of
BMI to identify them, are relevant in ILD which increases in prevalence with age. The study of body composition
in ILD is nascent, and limited evidence suggests both sarcopenia and obesity are associated with reduced quality
of life and exercise capacity, akin to the associations better established in chronic obstructive pulmonary disease.
Secondary cross-sectional analyses of two prospective cohort studies (R01 HL134851 [completed]; U01
HL163242 [ongoing]) are proposed to define the association between body composition and PCOs in adults with
advanced ILD undergoing lung transplantation evaluation. My central hypotheses are that abnormalities in body
composition will be associated with worse PCOs, that the magnitudes of association will be largest in participants
with sarcopenic obesity, and that these associations will not be apparent when using BMI as a primary exposure
variable. A projected 872 participants with baseline pre-transplantation visits will meet inclusion and exclusion
criteria and will be categorized by bioelectrical impedance as non-obese/non-sarcopenic, obese by fat mass,
sarcopenic, and sarcopenic obese. The outcomes of interest will be frailty by the Short Physical Performance
Battery and Fried Frailty Phenotype, exercise capacity by six-minute walk distance, disability by the Lung-
Transplant Valued Life Activities Scale, and general and respiratory-specific health-related quality of life by the
Short Form 12 and Airways Questionnaire 20-Revised, respectively. This proposal is significant by exploring a
novel and potentially intervenable risk factor for poor PCOs in a population already vulnerable to significant
morbidity, while also supporting my growth as an early-stage investigator through strong cross-disciplinary
mentorship alongside didactic and experiential training.

Public health relevance
Project Narrative Interstitial lung diseases (ILD) are diseases of lung scarring with significant effects on health outside of lung function, including patient-centered outcomes (PCOs) such as decreased quality of life, functional status, and ability to complete activities important to daily living. Changes in body composition, including increased body fat and decreased muscle mass, both of which occur with normal aging and are difficult to identify with body mass index (BMI), similarly affect quality of life. We plan to define the association between body composition and PCOs in patients with advanced ILD to characterize a potentially novel and intervenable risk factor for poor outcomes in a population already at significant morbidity.